Data Analysis Core

PROJECT ABSTRACT
The Data Analysis Core (DAC) is responsible for all aspects of data and metadata management, processing,
analysis, mapping, and sharing for this Tissue Mapping Center (TMC) and its Organ Specific Project (OSP)
focused on the pancreas. The DAC will support the TMC in these activities by providing a protected
environment for data storage and computation, and by developing robust reproducible, reusable, and scalable
computational workflows thus enabling the integration of data types into 3D maps for the purpose of creating
an interactive and queryable biomolecular human atlas. The DAC is an important part of the TMC in its
objectives to produce and deliver to the HIVE extensive sets of high-resolution spatial mappings of molecular
entities, using open formats, and within the context of the cellular and extracellular organization of the
pancreas.
Specifically, we will: (1) ingest and process TMC datasets; (2) analyze datasets in support of generating
multiscale, multiparameter tissue maps; (3) construct 3D tissue maps to integrate datasets; and (4) coordinate
planning with the HuBMAP Consortium.